In-Line 32-Channel Connector for High-Density Implantable Medical Device

DESCRIPTION (provided by applicant): The aim of this proposal is to develop the next generation of miniature, high- density multi-channel connectors suitable for chronic implantation in a patient's body as part of systems that are used, for example, to treat disorders of the peripheral nervous system. Maladies that could be treated in this way are problems with walking, such as after a stroke, and restoring natural sensations in a phantom limb after amputation. In this study, we will use custom-microfabricated connector bodies to facilitate interconnections within and among long-lasting neural interfaces. Custom packaging and assembly methods for the miniature connectors will also be developed. The tasks to be accomplished under this proposal include the fabrication of new HD connectors for mating with pre-existing micro-neurostimulator designs. We will also evaluate the long- term biocompatibility and bio-stability of these connectors through both in vitro experiments and animal surgical trials. The data collected will facilitate future application to the FDA to do follow-on clinical studies of medical devices incorporating high density connector technology. The relationship between the proposed effort and the patient care mission of the VA is that these improvements are expected to increase the interchangeability of components of implantable neurostimulation systems for rehabilitation that have high channel counts. This will improve new devices under development such as implantable walking aids and devices for restoring natural sensation in amputated limbs.

Public health relevance
PUBLIC HEALTH RELEVANCE: Lower extremity paralysis and/or weakness is common in the Veteran population. Specifically, motor nerve dysfunction due to stroke, incomplete spinal cord injury, or multiple sclerosis creates debilitating conditions that affect a Veteran's ability to walk, work, and engage in physical activity. High density stimulation technology for walking assistance has the potential to enhance functional independence by providing patients with a means to maneuver. As well, combat-related amputations have been steady. Existing prosthetic technology for amputees doesn't restore natural sensations in the amputated limb. Advanced peripheral neuroprostheses to address these conditions will require high density interconnections that are enabled by our proposed research effort. These systems will contribute to the distribution of new clinical interventions based on effective life enhancing technology to the Veteran population.